Administrative Core

PROJECT SUMMARY: Core A
The Administrative Core will provide centralized administrative and fiscal management for all research projects
and cores associated with the Program Project. Responsibility for the administrative and financial activities of
the Program Project will be headed by Director, Dr. Mary Estes and assisted by Co-Directors, Drs. Pedro
Piedra and Anthony Maresso, and staffed by a part-time senior administrator, LeAnn Cryer and a part-time
administrative secretary, Amey Neaville. Drs. Estes, Piedra, and Maresso will provide overall direction to the
scientific and administrative operations of the Program Project. Together, the Administrative Core leadership
will fulfill the responsibilities of coordinating the programmatic aspects of the research activities of the participants
and include fiscal overview, yearly progress report preparation and assembly, manuscript preparation,
organization and scheduling of meetings, seminar speakers, and the general allocation of resources.